Impact of Maternal Obesity on Offspring Non-alcoholic Fatty Liver Disease: Role of Bile Acid Homeostasis and Microbiome

PROJECT SUMMARY/ABSTRACT
The primary goal of this proposal is to develop the principal investigator, Dr. Michael Thompson, into an
independent physician scientist in the field of hepatology research. Michael has previously received PhD
training in cellular and molecular pathology with a focus on liver disease. At the current time, he has completed
clinical training in Pediatric Endocrinology and has designed a 5 year career development plan to provide
additional training in bile acid metabolism and microbiome research. At the end of this career development
award, he will become an independent investigator with his own lab program evaluating the developmental
origins of liver disease. Dr. Nicholas Davidson, Chief of Gastroenterology at Washington University, will mentor
the PI. Dr. Davidson is a well-known leader in intestinal and hepatic bile acid metabolism research and an
experienced mentor. Dr. Phil Tarr, Chief of Pediatric Gastroenterology at Washington University, will serve as
co-mentor for the PI. Dr. Tarr is a recognized leader in microbiome research which is a primary focus of this
proposal. The PI will take advantage of the abundant basic science and clinical resources available at
Washington University to develop his own clinically relevant basic research program.
Obesity and its complications affect 78 million adults and 13 million children with an estimated economic
impact of $2.0 trillion per year. Growing evidence supports that in utero and perinatal events drive risk for
insulin resistance and obesity associated complications such as nonalcoholic fatty liver disease (NAFLD) in the
offspring. Our preliminary findings indicate that alterations in bile acid homeostasis are associated with this
increased risk. This proposal will focus on defining the mechanisms behind the observed alterations in bile
acid homeostasis. I will utilize an established model of maternal high fat/high sugar diet exposure to test this
hypothesis. In the first aim, I will evaluate cholesterol absorption, bile acid excretion, and bile acid
metabolism/transport to define which are contributing to the increased bile acid pool size and composition. In
the second aim, I will define whether vertical transmission of the microbiome occurs across generations and
whether changes in the microbiome impact bile acid metabolism and metabolic liver disease in the offspring. In
the third aim, I will evaluate the efficacy of targeting the bile acid pool size or pool composition as a
preventative approach for metabolic liver disease offspring of obese dams. Specifically, I will treat offspring
with a bile acid sequestrant (cholestyramine) or a hydrophilic bile acid (UDCA) prior to feeding a western diet,
after which I will evaluate insulin resistance and steatosis. Identification of potentially pathogenic alterations in
bile acid pool composition, metabolism, and/or transport will support further hypothesis driven research design
to identify the mechanism of increased risk for disease progression. Once a mechanistic link is proven
between altered bile acid metabolism in offspring and risk for NAFLD progression, this information will be used
to design bile acid based preventative therapies to prevent disease progression in at risk patients.

Public health relevance
PROJECT NARRATIVE Obesity and its associated complications, including fatty liver disease, are a growing public health problem with a significant economic impact on the health system. Evidence indicates that maternal obesity predisposes offspring to fatty liver disease and insulin resistance, possibly via alterations in bile acid metabolism. I propose studies to define the mechanism of altered bile acid metabolism and test if treatments targeting these changes in bile acid metabolism are effective preventative therapies for metabolic liver disease.